Essential Cortical Mechanisms for Working Memory

Despite that many failures of high-level cognition are due to the limited resources that support working memory
(WM), we know almost nothing about the neural mechanisms underlying these WM limitations, nor the
strategies employed to mitigate the limits of our memory. This gap in our knowledge is critical because a host
of neuropsychiatric disorders suffer from WM dysfunction. Our long-term goal is to understand the mechanisms
by which WM representations are limited and how these limitations can be mitigated. Our overall hypothesis is
two-fold. 1) A network of cortical areas support WM, where the population dynamics within distinct nodes
encode and maintain stimulus features and mnemonic strategies. 2) The amount of available WM resources is
proportional to some properties of the node’s population (e.g., size) within which these dynamics reside. The
central aim of the project is to dissect the cortical network that supports WM, causally linking canonical WM
mechanisms to visual field maps in frontal, parietal, and occipital cortex, and identifying the underlying
mechanisms that limit WM. The rationale for the proposed research is that, as we better understand the neural
mechanisms of WM, a strong theoretical framework will emerge within which strategies for understanding
individual differences and treating cognitive dysfunction will emerge. Using functional brain imaging,
transcranial magnetic stimulation (TMS), and computational modeling, we test our central hypothesis by
pursuing three specific aims. 1) The structure of the neural populations that encode WM representations
constrain the precision, capacity, and resilience of WM; 2) Prefrontal and parietal cortex make critical but
distinct contributions to WM; and 3) Early visual cortex is necessary for the maintenance of visual WM. Strong
preliminary data demonstrate the feasibility of proposed work as well as initial support for the hypotheses.
Under Aim 1, the size of retinotopically-defined frontal and parietal visual field maps predicts both individual
differences in the precision of WM and the degree to which TMS affects WM. Under Aim 2, TMS to parietal
cortex impacts memory precision, while perturbation of frontal cortex affected the strategic allocation of WM
resources. Under Aim 3, TMS to primary visual cortex causes a loss of precision for remembered items
encoded in the perturbed portion of the visual field, supporting a model by which visual cortex acts as a
workspace for top-down feedback signals during WM. Overall, the proposed work will generate data needed to
dissect the cortical network that supports WM, causally linking canonical WM mechanisms to visual field maps
in frontal, parietal, and occipital cortex, and identifying the underlying mechanisms that limit WM. The approach
is innovative because it combines computational neuroimaging, modeling, and causal techniques to directly
test WM theories within a test bed of well-defined topographically organized populations. The proposed
research is significant because it is expected to provide key insights into the causes of WM limits in humans, in
addition to providing new targets for cognitive remediation in psychiatric, neurologic, and geriatric populations.

Public health relevance
The proposed research is relevant to public health because advancement in our understanding of the precise cortical mechanisms that support the wide range of working memory abilities will illuminate the mechanisms that could go awry in the pathological brain. Specifically, the proposed research is relevant to NIH’s mission because is expected to advance a stronger theoretical framework within which clinical researchers can develop strategies for the diagnosis and treatment of psychiatric and neurologic disorders.